Mali International Center for Excellence in Research: Filariasis

Over the past year, our research in Mali has made progress as follows:

1) Collection of data through in-depth interviews and focus groups in 2 health districts in Mali identified the main reasons for never treatment among displaced people, nomads and economic migrants in areas under mass drug administration. These included geographical mobility, lack of awareness/information, negative rumours, fear of side effects, conflict and insecurity and logistical difficulties faced in reaching these populations. Proposed solutions included involving communities in the MDA, increasing awareness and information campaigns, effectively managing side effects, and designing and implementing flexible and effective interventions.

2) Initiation of a pilot study of the causes of dysphagia among patients undergoing endoscopy at the Gabriel Toure Hospital